American Society of Andrology Annual Meeting

Project Summary
The American Society of Andrology (ASA) is a global, multidisciplinary professional society dedicated to the
science of men’s health. Founded in 1975, it has approximately 565 members from a wide range of
professions, research interests, and organizations. Our membership encompasses male reproductive biology,
genetics, endocrinology, urology, gynecology/obstetrics, biochemistry, veterinary science, molecular & cell
biology, and reproductive technologies. Roughly 10% of the members are trainees, i.e. students, residents and
fellows. Our overall goal is to advance research in basic, translational and clinical Andrology through a meeting
that is intellectually stimulating and professionally rewarding. Our annual meeting reflects the strength of our
membership. With its manageable size and diversity of interests, the meeting is a rich marketplace of ideas,
discussions, collaborations, and opportunities for training and employment. Innovation in science comes from
bringing concepts and approaches together in new ways. Our meeting provides these interactions. A vibrant
and diverse biomedical workforce comes from exposing students and trainees to investigators doing cutting-
edge research. Our meeting provides these introductions. As scientists, we produce not only data, but also our
next generation. In this conference application, we seek an additional five years of funding for trainee travel
awards for the Annual Meeting of the ASA. Our specific Aims have been updated but are similar to the
previous funding period. Aim 1: To deliver an outstanding scientific program covering the latest concepts and
progress in andrology, with an appropriate balance of clinical, translational, and basic scientific presentations.
Aim 2: To attract a diverse group of attendees from stakeholders with inclusion of professionals at all career
stages, women, minorities, and people with disabilities. Aim 3: To create a forum to establish research
collaborations between basic scientists and clinicians. Aim 4: To provide opportunities for career enhancement
and advancement at all professional stages. We anticipate that as a result of the ongoing Annual Meeting,
attendees will learn new findings to apply in their own research and/or practice. Participants will hear in depth
updates in their own specific areas. They will also be able to learn about advances and controversies in fields
outside their own. Andrology and related fields will benefit from the generation of new ideas and from the
formation of new professional contacts.

Public health relevance
As a result of the American Society of Andrology (ASA) Annual Meeting, scientists will learn new findings to further their own research in male reproduction. Healthcare providers will be able to translate advances in biology into improved prevention, diagnosis and management of male infertility and reproductive disorders. If funded, this grant would provide an additional five years of support for trainees to attend and benefit from the Annual Meeting.